Cancer Center Support Grant

PROJECT SUMMARY: OVERALL
The Fred Hutchinson/University of Washington Cancer Consortium (“the Consortium”) brings together more
than 600 members with research interests in basic, clinical and public health sciences related to cancer. The
goal of the Consortium is the elimination of cancer as a cause of suffering and death through more effective
prevention, diagnostics, and treatment, deriving from fundamental insights into the biology of the disease. The
extensive interdisciplinary collaboration among the partner institutions in the cancer research disciplines of
basic, clinical, and public health sciences affords new opportunities to reduce suffering and mortality from
cancer.
The Consortium was established in 2002 to build upon the complementary strengths and resources of three
partner institutions: the Fred Hutch, which has been an NCI-designated Comprehensive Cancer Center since
1976; the University of Washington, which has significant strength in cancer research, clinical care, and
teaching; and Seattle Children’s, the major pediatric academic center in the region. In 2008, the Seattle Cancer
Care Alliance, the cancer treatment center founded and equally co-owned by the three founding institutions,
was formally added to the cancer center designation.
The Consortium’s total funding base (direct dollars) is $242M, of which $117M is peer-reviewed, including
$50M from the NCI. During the last grant period, over 170 new faculty members joined the Consortium, adding
breadth and depth to our research and clinical capabilities. In the most recent year, we enrolled 1,338 patients
onto interventional treatment trials, of which more than 50% were investigator-initiated. The ratio of accruals to
newly registered patients was 28%.
The Consortium serves a catchment area of 13 counties in western Washington. This equates to the region in
which 83 percent of our patients reside. As the only NCI-designated comprehensive cancer center in a five-
state region (Washington, Wyoming, Alaska, Montana and Idaho), we not only seek to serve the health needs
of the catchment area through research, training, and outreach, but also to ensure high impact throughout the
larger region.
The Consortium continues to build upon historic strengths in basic cancer biology, immunology and
transplantation, pathogen associated malignancies, tumor specific translational research, computational
biology and studies of cancer etiology, prevention, and outcomes. The Consortium is well poised to continue its
exceptional level of research in these areas. The CCSG continues to have a high impact on the Consortium,
fostering new inter-institutional collaborations, strengthening the translational research platform, and
intensifying research efforts on problems of the catchment area. Partner institutions contributed nearly $1.2
billion in institutional support during the last project period, including investments in our laboratory and clinical
research infrastructure as well as in faculty recruitment and trainee support.

Public health relevance
PROJECT NARRATIVE: OVERALL There were an estimated 1.7 million new cases of cancer in the United States in 2018, and an estimated 609,000 deaths from the disease. Cancer is the second leading cause of the death in the U.S. The goal of the Fred Hutchinson/University of Washington Cancer Consortium is the elimination of cancer as a cause of suffering and death through more effective prevention, diagnosis, and treatment, deriving from fundamental insights into the biology of the disease.